Reducing Morbidity in Sickle Cell Disease-Prevent Acute Chest Syndrome system (PACSystem) pilot study

ABSTRACT
Background: Sickle cell disease (SCD) is chronic hemolytic anemia that causes irreversible organ damage
resulting in a shortened lifespan. As a pediatric hematologist, my career goal is to utilize implementation science
(IS) and health services research (HSR) methods to address the limitations of the health care system contributing
to the poor outcomes of children and youth with SCD. My previous work, funded by an Agency for Healthcare
Research and Quality (AHRQ) institutional K12 award, demonstrated that providers often have difficulty in
adhering to standard of care practices for inpatient pediatric SCD management. Complications such as acute
chest syndrome (ACS) could be reduced by an improved understanding of SCD providers’ attitudes and
perceptions and by developing targeted approaches to influence their behavior. Research: In this K08 award
proposal, there are three main aims: 1) to identify the barriers and enablers that healthcare providers face to
provide standard of care to patients with SCD; 2) develop an electronic health record (EHR) clinical decision
support system (CDSS), with employing a user-centered design approach and engaging healthcare providers;
and 3) pilot the CDSS using an IS framework on an inpatient pediatric SCD unit. The COM-B (Capability,
Opportunity, Motivation and Behavior) model will be used to guide design, data collection and analysis plans in
Aim 1 and the RE-AIM (Reach, Effectiveness, Adoption, Implementation and Maintenance) framework will guide
evaluation of the implementation outcomes in Aim 3. Training: I recently completed a Master of Science in Clinical
Research Methods which provided excellent introductory-level training in epidemiology, statistics, and principles
of stakeholder-engaged research. This K08 award will leverage my clinical expertise in SCD and provide training
in qualitative methods, IS, bioinformatics, advanced statistical methods and design and analysis of hybrid
effectiveness-implementation trials; these skills are essential to facilitate my transition to research independence.
Environment: The Department Chair of Pediatrics enthusiastically supports my application and ensures that
>75% of my time will be protected for research and education during the award. The Children’s Hospital at
Montefiore, affiliated with the Albert Einstein College of Medicine, is located in the Bronx, NY and has one of the
largest SCD cohorts in New York City. I have an excellent mentorship team of well-established researchers who
have guided my career to date, supported the publication of multiple manuscripts and advised on the preparation
of the K12 and K08 applications. Additional mentors for this proposal will add to the skills I need to become a
successful independent researcher. Long-term goal: My goal is to become an independent National Institutes of
Health-funded HSR investigator who can effectively conduct stakeholder-engaged research and implement
health systems interventions to positively impact the health of SCD patients in the United States.

Public health relevance
PROJECT NARRATIVE Acute chest syndrome (ACS) is a common respiratory complication of sickle cell disease (SCD). It results in irreversible lung damage, can be prevented by standard of care practices such as incentive spirometry and appropriate opioid orders, yet adherence to guidelines is suboptimal. This research will investigate the barriers and enablers of implementing best practices by SCD providers in a vulnerable, predominantly low-income pediatric SCD population in New York. This information will inform the development of a clinical decision support system (CDSS) and subsequent pilot study in the context of a hybrid effectiveness-implementation study design.